Biobehavioral markers of prenatal resilience associated with positive postpartum maternal mental health and well-being

PROJECT SUMMARY/ABSTRACT
Exposure to chronic life stress is associated with increased risk for postpartum depression and anxiety. However,
many individuals fare well in the postpartum period despite these exposures. This may, in part, be due to positive
experiences early in life and/or prenatal biobehavioral resilience (e.g., greater heart rate variability [HRV], self-
reported tenacity), although longitudinal studies examining mechanisms that promote postpartum well-being
have been limited. Thus, this K01 application is informed by a strengths-based framework to test the central
hypothesis that, in the context of chronic stress, experiences of positive parenting and supportive peer relations
during childhood will be associated with physiological and self-reported psychological resilience in pregnancy
(Aim 1), which, in turn, will predict early positive postpartum mental health and well-being (Aim 2). In Aim 3, novel
machine learning (ML) algorithms will extract multi-level data to test the mediating role of prenatal biobehavioral
resilience in the association between positive childhood experiences and postpartum mental health and well-
being. ML uses decision trees to find and extract cross-validated, generalizable features in rich, multimodal, time-
series data to maximize the likelihood of traditional mediation models. Participants who have experienced chronic
stress from ages 8-17 years (N=116) will be recruited from a population-based sample of pregnant people (67%
Black, 28% white, 5% mixed-race; 99% cis-female) enrolled in the longitudinal Pittsburgh Girls Study (PGS) that
began in childhood. At 20-30 weeks gestation, HRV will be measured using a wearable, passive sensor for 7
days and psychological resilience will be assessed by self-report. At 3-months postpartum, mental health and
well-being will be measured. These new data will be linked to extant PGS data on positive childhood experiences
that were measured prospectively from 8-17 years. The award candidate, Dr. Magee, is a licensed clinical
psychologist experienced in studying mood and behavior around key life transitions. Dr. Magee will gain
specialized conceptual and methodological training in: (1) developmental models of stress, resilience, and
peripartum mental health and well-being; (2) acquiring, processing, analyzing, and interpreting ambulatory
cardiovascular psychophysiological data; and (3) ML and deep learning techniques to extract multi-modal data.
Dr. Magee’s training and research will be supported by a strong team of mentors (Drs. Hipwell, Levine, Bylsma,
and Akcakaya) and a consultant (Dr. Cheng) with expertise that spans domains of preconception stress and
resilience, postpartum mental health, ambulatory assessment of prenatal psychophysiology, multilevel modeling,
and ML techniques. The University of Pittsburgh is a leading research institution that will provide an exceptional
training environment for Dr. Magee to meet her research and career development goals. The proposed K01
research aligns with and advances the NIMH’s mission and scientific priorities and is the first step in Dr. Magee’s
goal to create a larger program of independent research focused on identifying promotive factors that inform the
development of peripartum mental health interventions.

Public health relevance
PROJECT NARRATIVE Exposure to chronic stress is associated with increased risk for postpartum depression and anxiety, but there is substantial variability in these outcomes that is not well understood. This K01 application is informed by a life course, strengths-based framework to test the central hypothesis that positive childhood experiences and prenatal biobehavioral resilience will predict positive postpartum mental health and well-being among individuals who have experienced chronic stress, with potential utility for biofeedback preventive interventions. The implications of the proposed work are particularly relevant to historically marginalized individuals who are disproportionately affected by chronic stress that contributes to disparities in maternal morbidity and mortality in the United States.